The effects of ketogenic diet on alcohol intoxication

PROJECT SUMMARY/ ABSTRACT
The ketogenic diet (KD) has previously been shown to reduce alcohol withdrawal symptoms and cravings and
emerged as a potential treatment option for alcohol use disorder (AUD). However, a preclinical study
demonstrated higher blood alcohol concentrations in alcohol-administered rats maintained on KD compared to
those on a standard chow diet. This raises concerns for heightened intoxication and associated risks for alcohol
poisoning and reckless behaviors in individuals on KD. Furthermore, a previous study in our laboratory
demonstrated elevated neurotransmitter glutamate in individuals adhering to KD compared to standard American
diet (SA), and changes in levels of neurotransmitters glutamate and GABA may exacerbate the intoxicating
effects of alcohol. Therefore, the overall objective of this proposed study is to examine the neuropharmacological
effects of KD on alcohol intoxication. The K99 phase (Aims 1 and 2) will take advantage of cutting-edge magnetic
resonance spectroscopy (MRS) methodologies to measure brain glutamate and GABA, as well as assess
subjective and objective indices of alcohol intoxication in healthy individuals. Given previous evidence suggesting
that chronic alcohol intake produces tolerance in individuals with AUD, the R00 phase (Aim 3) will focus on non-
treatment-seeking individuals with AUD. We propose a randomized, cross-over design in which participants will
receive a 2-week KD and a 2-week standard American diet in randomized order. Following the dietary
intervention, participants will be assessed for brain levels of glutamate and GABA and responses to an alcohol
challenge using breath alcohol concentration, motor and cognitive tests, and self-reports of intoxication on
validated questionnaires. We hypothesize that adherence to a KD will elevate brain glutamate and GABA levels
and slow alcohol metabolism, exacerbating alcohol intoxication symptomatology. The findings may have public
health implications for better understanding factors mediating alcohol intoxication and identifying the safety of
KD as a potential AUD therapy. The research outlined above will also provide the applicant with training to
facilitate a successful transition from a mentored postdoctoral fellow to an independent researcher. Specifically,
it will enable Dr. Li to achieve five training goals: 1) hands-on experience in the clinical and regulatory aspects
of clinical research, 2) proficiency in MRS methodologies, 3) application of neuropsychiatric assessments and
behavioral paradigm, 4) leadership skills, and 5) general independent research skills. Through a combination of
didactic and hands-on activities, the project will fulfill Dr. Li’s training needs and enable her to transition to a
successful and independent research career.

Public health relevance
PROJECT NARRATIVE The proposed K99/R00 project aims to elucidate the effects of a ketogenic diet, compared to a standard American diet, on brain glutamate and GABA levels and objective and subjective indices of alcohol intoxication in healthy individuals (K99) and individuals with alcohol use disorder (R00). Findings from this project will contribute to our understanding of factors underlying alcohol intoxication and caution individuals at higher risks for alcohol poisoning and alcohol-related harms. The project will also provide Dr. Li with fundamental training in leading clinical addiction research and facilitate her transition to an independent researcher.